Glioblastoma-secreted GABA contributes to the immunosuppressive environment

Title: Glioblastoma-secreted GABA contributes to the immunosuppressive environment
Abstract:
Glioblastoma (GBM) is one of the most common and lethal human brain tumors and there are no
effective treatments. We have shown that immune cells have GABA-receptors (GABA-Rs) and that their
activation limits inflammatory immune responses. Indeed, three recent studies of several different types of
peripheral solid tumors have demonstrated that tumor cells, or B cells within tumors, can secrete GABA which
dramatically shifts the phenotype of human and murine tumor-infiltrating macrophages and dendritic cells
towards anti-inflammatory phenotypes and inhibits the activity of infiltrating CD8+ effector T cells, consistent
with our findings of GABA’s action in autoimmune diseases. GABA-R antagonists, or inactivation of the GABA-
synthesizing enzyme glutamic acid decarboxylase (GAD67), significantly decreases tumor burden in these
models. Thus, GABA is an important intra-tumor immunosuppressive factor in these peripheral tumors.
There are multiple lines of evidence indicating that glioblastoma cells secrete high levels of GABA. Our
central hypothesis is that GBM-secreted GABA contributes to the immunosuppressive tumor environment. Our
proposed studies with GAD67-deficient GBM cell lines will determine 1) whether GBM-secreted GABA
modulates the frequency, phenotype, and localization of tumor infiltrating immune cells, 2) how GABA
deficiency modulates GBM gene expression, and 3) whether rendering GBMs GABA-deficient confers a
survival advantage.
These investigations will collectively provide the first understanding of how GBM-secreted GABA
transforms the tumor microenvironment and affects survival. If our central hypothesis is supported, future
studies can examine whether making anti-tumor responses resistant to GABA inhibition could improve their
effector functions. For example, we may be able to enhance the effectiveness of NK, DC, or T cell-based
therapies by making them GABA-R deficient. Alternatively, new therapies may be designed to specifically
target immune cell GABA-Rs or their signaling pathways.

Public health relevance
Relevance to Public Health: We will test the hypothesis that glioblastoma-secreted GABA contributes to the immunosuppressive tumor environment. The results will provide new insights into the glioblastoma biology and suggest new therapeutic approaches.